The University of Kentucky Racial Equity Initiative Coordinating Center (UK-REI-CC)- Administrative Supplement

SUMMARY
The overarching goal of the University of Kentucky Racial Equity Initiative Coordinating
Center (UK-REI-CC) is to focus on collectivism and elevate the resilience of People of Color and
Indigenous (POCI) communities through supporting REI grantees to conduct culturally relevant,
best practice, community engaged substance use research. UK-REI-CC will draw from the
Radical Healing in Communities of Color,6 a strength-based framework, to coordinate projects
from both Highly Resourced Institutions (HRIs) and Limited Resourced Institutions (LRIs). The
UK-REI-CC is led by a PI and faculty with established collaborations and extensive experience
focused on community-engagement, drug treatment, HIV, randomized controlled trials,
implementation science, pharmacology, and justice-involvement. In collaboration with the NIDA
Steering Committee and expert panel UK-REI-CC will complete the following aims: 1) To
develop and support a learning community through networking & training among REI grantees.
UK REI-CC will organize and convene a kick-off, annual meetings, and monthly meetings of REI
grantees. Using Pure™ network mapping system,7 REI grantees and community partners will
access investigators and their worldwide networks. UK-REI-CC will conduct a bi-annual needs
assessment, convene, workgroups, devise quarterly trainings, develop a speaker series, and
host networking events encouraging collectivism and highlighting assets among the REI
institutions. 2) To enhance REI projects by providing research resources focused on community
engagement. UK REI-CC will provide technical assistance and consultations focused on
elevating the voices of marginalized communities. The center will provide quarterly trainings to
REI project sites and resources focused on building and strengthening academic-community
partnerships. 3) To optimize data collection and analyses by the REI community. Using
Tableau, UK-REI-CC will host an interactive dashboard illustrating progress for REI projects.
The center will provide consultation on devising research questions, culturally appropriate
measures, recruitment and retention strategies, qualitative and quantitative data analyses, and
incorporating community partners in data analyses. 4) To facilitate broad and accessible
communication and dissemination of REI project findings for end users. UK REI-CC will develop
online resources to share press releases, publications, and research presentations. In addition,
the UK-REI-CC will leverage our expertise in culturally tailoring messaging to ensure
accessibility for all communities participating in the research. Taken together, these activities
will enhance the capacity for REI projects to conduct impactful substance use research.

Public health relevance
Project Narrative: The UK-REI-CC is an innovative coordinating center model centering collectivism and emphasizing the resilience of racial and ethnic marginalized communities. The UK-REI-CC will enhance and support the NIDA REI projects by providing resources for networking and training, conducting community- engaged research, data collection and analyses, and communication and dissemination. An administrative supplement is being requested to support unanticipated changes in personnel costs requiring multiple subawards.